Hematology Training

PROJECT SUMMARY / ABSTRACT
The Hematology Research Training Program at the University of Washington and Fred Hutchinson Cancer
Center (Fred Hutch) is designed to provide intensive post-doctoral research training in investigative hematology.
Although the program emphasizes cell and molecular biology, and has well-established strengths in stem cells,
hematopoiesis, thrombosis, hemostasis, sickle cell disease, marrow failure, hematologic malignancies,
immunotherapy, gene therapy, and hematopoietic cell transplantation; clinical research and outcomes
investigation are also energetically supported and encouraged. Program faculty include established investigators
with strong independent research programs from both basic science and clinical departments of the University
of Washington and Fred Hutch. The faculty is based at the University of Washington campuses, the Fred Hutch
clinical and research buildings, BloodWorks NW Research Institute, Washington Center for Bleeding Disorders
(hemophilia 340B program site), Harborview Medical Center (safety-net hospital), and Seattle Children’s Hospital
Research Institute. The goal of the training program is to develop the research, presentation, and grant-writing
skills that trainees will need to establish independent research careers, and more specifically, to train future
leaders in academic hematology and replenish the hematology workforce. Trainees have MD, MD/PhD, or PhD
degrees. Many have completed clinical fellowship training in hematology, but others are basic researchers in
hematology topics. Trainees are chosen through an application process and interviews with program faculty.
They obtain research experience by working with a mentor, and gain skills in laboratory and/or clinical
investigation, data analysis, publishing papers, presentation, and acquiring independent grant support.
Bidirectional translational projects (bench to bedside and bedside to bench) are encouraged. Trainees typically
receive two years of funding from the T32 program, but often continue their training longer under separate
funding mechanisms, including K grants and foundation support. Training progress is monitored by the faculty
mentor, a separate faculty advisor, the Program Directors, and the Division of Hematology and Oncology faculty
through regular research presentations, meetings with each trainee, and written evaluations. Every six months,
trainees update their individual development plan (IDP) and formally present their research progress and career
goals to a Research Oversight Committee (ROC) consisting of the trainee’s mentors and the T32 PI. Consistent
with our mission, 95% of trainees who completed our program over the past 10 years have academic medicine
or industry research careers. Strengths of the program include: the diverse research opportunities, a prominent
senior faculty, the inclusion and mentorship of talented junior faculty, the structured mentorship of trainees, the
inclusion of underrepresented minority trainees, strong and varied didactic sessions, and a long track record
spanning over five decades of training graduates that subsequently obtain academic or industry research
positions and become independent, distinguished investigators and thought-leaders throughout hematology.

Public health relevance
PROJECT NARRATIVE There continues to be a need for rigorous scientists, and especially physician-scientists, in the field of hematology since this discipline is at the forefront of translational investigation and molecular medicine and is understaffed. This grant will support the training of hematology researchers at a critical time in their careers - the transition from post-doctoral fellow to independent investigator - and thus advance basic, translational, and clinical hematology research and health care in the USA.